Genetics of zebrafish germ layer formation

Project 1) Dr. Feldman supervised the successful completion and defense of Jamie Browns (ne Boorech) Ph.D. dissertaion. The work she has done will go towards a manuscript on how extraembryonic signals drive mesoderm patterning. Project 2) Dr. Feldman has been engaged in library research and writing for a chapter in an upcoming textbook. Project 3) A manuscript on RhoGEF functions during gastrulation was submitted and Dr. Feldman is currently addressing reviewer comments.    Project 4) Using RNA-seq data generated in 2011-12, we defined a comprehensive list of transcription factors expressed during blastula stages of development. We have obtained a nanostring codeset for 50% of these transcription factor genes and we are in the process of obtaining a codeset for the remaining 50%. These two code sets will be used to generate a high-resolution temporal profile of transcription factor expression, which will be a valuable resource for assembling developmental gene regulatory networks.   Project 5) We are analyzing data from experiments performed in past years, which will lead to two manuscripts describing a new strategy for quantifying the activity of ectopically expressed genes in zebrafish as applied to candidate human holoprosencephaly genes. A manuscript from related work was published last year.